Development of stretchable optical sensors for measurement of penile hemodynamics

Project Summary/Abstract
Erectile dysfunction (ED) is a progressive disease, which is often characterized by rampant fibrosis of
the corpus cavernosum in severe disease states. It is hypothesized that hypoxia resulting from inadequate
blood perfusion and/or depressed oxygenation is a primary driver of the fibrotic process in the corpus
cavernosum. Moreover, ischemic priapism is highly prevalent in men with sickle cell disease. In these
instances, sickling of the erythrocytes obstructs venous outflow from the corporal bodies, resulting in prolonged
erections with minimal inflow of new blood into the penis. This stagnation of blood in the penis results in severe
penile hypoxia despite the presence of a prolonged erection, which ultimately leads to advanced erectile
function. This proposal is in response to PAR-23-119 “Catalytic Tool and Technology Development in Kidney,
Urologic, and Hematologic Diseases”. Our goal is to develop a wearable device for prolonged penile oxygen
saturation monitoring that can contour to the skin of the penile shaft, that is also flexible to movement and
stretchable for expansion during erection. This proposal leverages our team’s recent innovation of a
stretchable optical sensor photodiode for wearable photoplethysmography. We seek to optimize and validate
this technology in rodents before advancing to testing in human patients. There are two specific aims to this
proposal. Aim 1 is to design and fabricate optical sensors for rodent penile hemodynamic monitoring. Aim 2 is
to determine if changes in measured oxygen saturation correspond with changes in rodent intracavernous
pressure upon erection induction. Multiple variables can influence the oxygen saturation signal attained from
photoplethysmography, as well as the depth within the tissue that the signal is obtained from. Major variables
include the composition of the tissue through which light must penetrate, the wavelength of light emitted from
the light source, and the light intensity emitted from the source. For this project, we will use both mice and rats
due to the difference in thickness of the penile fascia, tunica albuginea, and cavernous smooth muscle and
collagen through which light must penetrate and reflect off of oxygenated hemoglobin in the sinusoids. Devices
will be fabricated to form fit the mouse and rat penile shaft, with three prototypes for each that contain micro
light emitting diodes that emit different wavelengths of light. Three different light intensities will be used while
testing each wavelength. Variable changes in intracavernous pressure will be induced by stimulation of the
cavernous nerve with variable voltages. Additionally, both rapid and prolonged erections will be induced by
intracavernous injection of sodium nitroprusside and papaverine.

Public health relevance
Project Narrative: Erectile Dysfunction is highly prevalent in American men, the severity of which is believed to be due in part to decreased oxygenation of the corpus cavernosum. The current method for measurement of penile oxygenation is through needle aspiration of penile blood, which is impractical for prolonged monitoring purposes due to patient discomfort and potential of further tissue damage. We seek to leverage our team’s recent innovation of a stretchable and flexible photodiode to create a wearable device for prolonged penile oxygen tension measurement that contours to the skin and stretches with movement, which we first seek to optimize and validate in a rodent model.